The role of extracellular matrix in primary sclerosing cholangitis

Primary sclerosing cholangitis (PSC), is a devastating cholestatic liver disease, characterized by segmental
inflammation and fibrosis of the bile ducts. PSC still has no accepted therapies, and the VA population is
increasingly affected. The extracellular matrix (ECM), and hyaluronan (HA), is abundant in PSC, surrounding the
affected areas. The mechanism by which HA modulates the ECM in early PSC, mechano-cellular and immune
responses, are unknown. In our studies, we found that HA is abundant in patients with PSC and in mouse
models prior to the deposition of collagen, and that high molecular weight (HMW) HA induces matrix stiffening,
tested in a novel 3D adjustable stiffness hydrogel model, and in DDC diet by atomic force microscopy (AFM).
We depicted CD44/Integrin-β1 as mechanoreceptors that transmit YAP-mediated proliferative responses and a
ductular reactive cell (DRC) phenotype. Furthermore, treatment of DDC-fed or Mdr2-/- mice with 4-
methylumbelliferone gluconate (4-MUG), an inhibitor of HA synthesis, reduced stiffness, and downregulated pro-
inflammatory cytokines. Thus, we hypothesize that the changing ECM architecture and mechano-signaling elicit
phenotypic changes in cholangiocytes as well as modulate macrophage polarity and effector functions in PSC.
We propose three SPECIFIC AIMS to address the key areas generated by this hypothesis:
Our first aim is to determine the role of hyaluronan modulating early matrix changes and mechano-signaling in
PSC. 1) We propose to study the role of high and low molecular weight-HA in mouse models of PSC by second
harmonic generation and CT-FIRE microcopy, as well as matrix mechanics (rheometry, AFM), in 3D
alginate/collagen hydrogels. 2) We will investigate mechanosensitive pathways, focusing on CD44 and integrin
β1 interaction and the role of YAP/TAZ activation in cytoskeletal rearrangement, proliferative responses and
hyaluronan synthetase (HAS1, 2) production in an autocrine cycle. 3) ECM changes, mechano-signaling, and
DRC will be studied in models of PSC, combined with HAS inhibition. Cell-specific mechano-signals will be
evaluated in a novel conditional, inducible cholangiocyte CD44KO model (CD44 fl/fl X Opn-iCreERT2 mice), on
DDC diet. In aim 2 we will explore how the stiffening matrix in PSC affects macrophage phenotypic and functional
behavior. 1) We will evaluate the mechanism of podosome formation, mechano-sensation and migratory activity
linked to phenotypic changes. 2)The effects of stiffening matrix on macrophage phagocytosis and efferocytosis
will be assessed. The molecular events of phagosome maturation and expression of “don’t eat me signals” will
be evaluated. 3) Monocyte/macrophage mobilization, trafficking, and fate will be studied in the hCD68-GFP
transgenic mice on DDC diet. The dynamics of GFP-labeled cells will be studied by CyTOF during disease
progression. In the third aim, the effects of HAS inhibition will be tested in PSC models, and in patient liver
samples. 1) We will study the dynamic changes elicited by HAS inhibition on inflammation and fibrosis. We will
garner information at a single cell level, using Codex, assessing the dynamics of cell interaction across the entire
landscape. 2) De-identified biopsy samples from the Stanford Tissue Bank and a pilot PSC trial using 4-MU vs.
standard of care will be obtained. AFM will be performed on the peri-biliary areas. To explore cholangiocyte
and macrophage plasticity/interactome, we will use a spatial transcriptomic platform (Visium). These studies will
fill the gap in knowledge regarding matrix-mediated regulation of cell plasticity and elucidate early changes in
PSC. HAS targeting could become a feasible an effective approach to halt disease progression.

Public health relevance
Primary sclerosing cholangitis (PSC) is one of the most severe types of cholestatic liver diseases, affecting an increasing number of patients at the Veterans Administrations, leading to hospitalizations with significant rate of mortality. Currently, there no treatment approaches available for PSC, and liver transplantation is available for only select cases. PSC is characterized by significant accumulation of matrix around the affected areas, and as to how the matrix affects and cross-talks with bile duct cells, have not been well explored. Thus, there is an urgent need to understand the pathogenesis of PSC focusing on early stages and the role of the ECM. Based on the data generated we propose to use a novel therapeutic approach to reduce mortality in PSC.